Neuroscience Gateway to Enable Dissemination of Computational And Data Processing Tools And Software.

Abstract (Proposal title: Neuroscience Gateway to Enable Dissemination of Computational and Data Processing Tools and
Software.): This proposal presents a focused plan for expanding the capabilities of the Neuroscience Gateway (NSG) to
meet the evolving needs of neuroscientists engaged in computationally intensive research. The NSG project began in 2012
with support from the NSF. Its initial goal was to catalyze progress in computational neuroscience by reducing technical
and administrative barriers that neuroscientists faced in large scale modeling projects involving tools and software which
require and run efficiently on high performance computing (HPC) resources. NSG's success is reflected in the facts that (1)
its base of registered users has grown continually since it started operation in early 2013 (more than 800 at present), (2)
every year the NSG team successfully acquires ever larger allocations of supercomputer time (recently more than
10,000,000 core hours/year) on academic HPC resources of the Extreme Science and Engineering Discovery (XSEDE –
that coordinates NSF supercomputer centers) program by writing proposals that go through an extremely competitive peer
review process, and (3) it has contributed to large number of publications and Ph.D thesis. In recent years experimentalists,
cognitive neuroscientists and others have begun using NSG for brain image data processing, data analysis and machine
learning. NSG now provides over 20 tools on HPC resources for modeling, simulation and data processing. While NSG is
currently well used by the neuroscience community, there is increasing interest from that community in applying it to a
wider range of tasks than originally conceived. For example, some are trying to use it as an environment for dissemination
of lab-developed tools, even though NSG is not suitable for that use because of delays from the batch queue wait times of
production HPC resources, and lack of features and resources for an interactive, graphical, and collaborative environment
needed for tool development, benchmarking and testing. “Forced” use of NSG for development and dissemination makes
NSG's operators a “person-in-the-middle” bottleneck in the process. Another issue is that newly developed data processing
tools require high throughput computing (HTC) usage mode, as opposed to HPC, but currently NSG does not provide access
to compute resources suitable for HTC. Additionally, data processing workflows require features such as the ability to
transfer large size data, process shared data, and visualize output results, which are not currently available on NSG. The
work we propose will enhance NSG by adding the features that it needs to be a suitable and efficient dissemination
environment for lab-developed neuroscience tools to the broader neuroscience community. This will allow tool developers
to disseminate their lab-developed tools on NSG taking advantage of the current functionalities that are being well served
on NSG for the last six years such as a growing user base, an easy user interface, an open environment, the ability to access
and run jobs on powerful compute resources, availability of free supercomputer time, a well-established training and
outreach program, and a functioning user support system. All of these well-functioning features of NSG will make it an
ideal environment for dissemination and use of lab-developed computational and data processing neuroscience tools.

Public health relevance
The Neuroscience Gateway (NSG) was first implemented to enable large scale computational modeling of brain cells and circuits used to study neural function in health and disease. This new project extends NSG's utility to support development, dissemination and use of new tools by the neuroscience community for analyzing enormous data sets produced by advanced experimental methods in neuroscience.